SIZE REQUIREMENT DETERMINATION OF CHEMOKINES FOR HS OLIGOSACCHARIDES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This project is part of the effort to define the heparan sulfate (HS) binding site of chemokines. Specifically, the aim of this project is to determine the minimum size of HS required for binding to these proteins.